Idaho INBRE Program- UI Equipment Upgrade for INBRE Data Science Core

PROJECT SUMMARY
This Idaho INBRE Program Administrative Supplement will fund equipment that improves the
high-performance computing infrastructure in our Data Science Core facility at the University of
Idaho (UI). This equipment will enhance the accessibility and impact of this IDeA-built core in
the Institute for Interdisciplinary Data Sciences (IIDS). The IIDS is the legacy of 20-years of NIH
IDeA investment through both the INBRE and COBRE funding mechanisms and is now
independent from NIH direct support. IIDS is one of three sites across Idaho that together
comprise the Idaho INBRE Data Science Core and serves investigators statewide. In FY21,
IIDS core facilities supported the research of 83 faculty and 190 trainees from 9 different
Colleges, 30 academic departments, and 10 centers and institutes. Of these 273 researchers,
70% of them relied in some way on computational infrastructure. IIDS is also a nexus of
statewide collaboration, offering services to all Idaho INBRE Network institutions. IIDS houses
state-of-the-art equipment, high performance computing infrastructure, secure data storage, and
technical expertise in bioinformatics, data science, and software engineering. The requested
equipment purchase will upgrade and enhance the previous and ongoing NIH IDeA investments
in Idaho infrastructure, equipment, and faculty/staff related to bioinformatics, high performance
computing and data science. The addition represents necessary upgrades to our existing
capacity for secure data storage, large scale bioinformatics analyses, and hardware suitable for
AI applications. We have experienced dramatic surges in demand for computation and data
storage and anticipate that this demand will grow further as Idaho INBRE research activity
increases. Our current data storage systems (900 Tb) are over 90% full and the proposed
equipment will effectively double our capacity while simultaneously replacing aging equipment.
In addition, this equipment request will add critically needed capacity to accommodate the
increase in demand for genome assemblies using long read sequencing data from our Pac Bio
sequel II. Finally, GPU cards will meet the growing demand for hardware suitable for deep
learning and other AI research, a capacity not currently available at other sites within the Idaho
INBRE network. Collectively, this INBRE Administrative supplement will add important
equipment to enhance the capabilities for biomedical researchers state-wide.

Public health relevance
PROJECT NARRATIVE This supplement requests critical equipment upgrades to the Idaho INBRE Data Science Core as high performance computing hardware, including secure data storage and computational capacity. These upgrades will Idaho INBRE research facilites keep pace with recent surges in demand for computation and data storage.